PROGRAMMABLE IMPLANTABLE MEDICATION SYSTEM (PIMS) IN DIABETES

This study tests the safety and efficacy of the Programmable Implantable Medication System (PIMS), an insulin infusion pump which is implanted under the skin.